Persistent transcriptional changes induced by nickel through epigenetic alterations

Project Summary
Nickel (Ni) compounds are environmental toxicants, prevalent in the atmosphere due to their use in several
industrial processes, as well as extensive consumption of Ni containing products such as stainless steel,
batteries, medical devices and medical implants. In addition, combustion of fossil fuels is a major source of Ni
contamination in the atmosphere. Exposure to Ni is a major human health hazard, associated with a multitude
of health risks including allergic contact dermatitis, bronchitis, pulmonary fibrosis, and pulmonary edema.
Moreover, epidemiological studies indicate cancer development as a major outcome of Ni exposure. However,
the molecular basis of Ni-induced diseases remains poorly understood. To better understand the molecular
mechanisms underlying Ni-induced diseases, we investigated the effects of Ni-exposure on human epithelial
cells. Our studies show that Ni-exposure-induced gene expression changes persist long after the cessation of
exposure. This resulted in the cells undergoing epithelial-mesenchymal transition (EMT), and the EMT
phenotype continued long after the termination of exposure. EMT is the process in which polarized epithelial
cells lose cell-cell adhesion and acquire invasive and migratory mesenchymal properties. EMT is implicated in a
number of diseases associated with Ni-exposure including asthma, fibrosis, cancer and metastasis. Therefore,
our results suggest that persistent transcriptional changes caused by Ni exposure are likely important in the
etiology of Ni-exposure associated diseases. The overarching goal of this grant is to understand the
mechanisms that drive long-term transcriptional changes caused by Ni exposure. Our preliminary results suggest
that Ni-exposure disrupts chromatin regulation mediated by the histone modification, H3K27me3 and the zinc
finger protein, CTCF. Based on our preliminary results, we hypothesize that Ni-exposure increases
chromatin accessibility through H3K27me3 loss, causing gene upregulation. CTCF binds the newly
accessible chromatin and prevents H3K27me3 re-establishment after termination of Ni-exposure,
thereby persistently altering gene expression. In Aim 1, we will investigate the role of H3K27me3-loss in Ni-
induced persistent gene expression alterations in human lung epithelial cells. In Aim 2, we will investigate the
mechanisms underlying Ni-induced persistent chromatin alterations by knocking-down CTCF and by disrupting
CTCF binding sites using CRISPR/Cas9 system to examine if loss of CTCF binding could reverse Ni-induced
persistent transcriptional changes. In Aim 3, we will examine the functional outcome of Ni-induced persistent
transcriptional changes by investigating the tumor generating potential of Ni-exposed cells in in mice. The overall
impact of our study will be the identification of the mechanisms underlying long-term transcriptional changes
caused by nickel exposure, which will reveal the molecular basis of its pathogenicity, and will have major human
health implications.

Public health relevance
Project Narrative Nickel (Ni) compounds are environmental toxicants, prevalent in the atmosphere due to their widespread use in several industrial processes, as well as extensive consumption of Ni containing products. Although Ni- compounds have been conclusively shown to be associated with a multitude of human health risks including allergic contact dermatitis, bronchitis, pulmonary fibrosis, pulmonary edema and lung and nasal cancers, the molecular basis of Ni-induced diseases remain poorly understood. This study will investigate the mechanisms underlying Ni-induced diseases by examining the long-term changes to the transcriptome and epigenome that occur due to Ni exposure.